The Gonorrhea Vaccine Cooperative Research Center

ABSTRACT
The overall goal of the Gonorrhea Vaccine Cooperative Research Center (GV CRC) is to advance promising
vaccine candidates towards further preclinical development and clinical trials. The proposed GV CRC is
organized around four Research Projects, which collectively will address the large research gap regarding
correlates of vaccine-induced immunity against gonorrhea using human samples from individuals and mice
vaccinated with the 4CMenB vaccine for which there is evidence of protection against gonorrhea (Project 1) and
develop candidate gonorrhea vaccines against promising Ng surface molecules using vaccine platforms with
proven safety and manufacturability, specifically OMV vaccines (Project 2), nanodisc-displayed protein subunit
vaccines (Project 3) and epitope-tagged virus-like particle vaccines (Project 4). The choice of vaccine targets is
based on sequence conservation, capacity to induce bactericidal antibodies (Abs), in vivo efficacy in the mouse
model, and, or recognition by Abs from mice immunized with 4CMenB, which accelerates Ng clearance in the
female mouse model of lower genital tract infection. Vaccine immunogens will be prepared by a centralized core
(Core B) to ensure consistent and controlled preparations, and all vaccine candidates will be subjected to a
systematic and rigorous evaluation process that uses state-of-the-art immunological assays (Cores C and D)
and animal infection models (Core E) through the participation of four centralized Scientific Cores. An
Administrative Core (Core A) will provide the infrastructure needed to facilitate communications between the
different institutions within the center and with NIH/NIAID program staff, and coordinate teleconferences and
meetings among the Project and Core leaders to foster data exchange, internal peer review and collaboration.
A standing outside Scientific Advisory Board will review scientific progress in years 2 and 4, and determine which
vaccines will be advanced for further pre-clinical development.

Public health relevance
PROJECT NARRATIVE The work of the proposed Gonorrhea Vaccine Cooperative Research Center (GV CRC) is highly relevant to public health due to its emphasis on developing vaccines to prevent gonorrhea and curb the spread of antibiotic resistance.